A Novel Electrochemical LFA for Diagnosing TB from a Single Drop of Blood

Tuberculosis (TB) causes over 1.3 million deaths per year and active TB (ATB) disease in over 10 million new
individuals annually. However, in 2022, over 40% of reported TB patients were diagnosed based only on
clinical judgment, while an additional ~3 million individuals with ATB were neither detected nor reported. This
lack of diagnostic rigor results in an inefficient health system that perpetuates TB transmission, fuels drug
resistance, and jeopardizes global goals to end TB by 2035. Current diagnostic solutions depend on the
detection of Mycobacterium tuberculosis (Mtb) in patient sputum, despite sputum's limitations as a diagnostic
sample, making it difficult to obtain from patients with paucibacillary TB, such as those living with HIV (PLWH),
young children, and patients with extrapulmonary TB. While rapid, sputum-based molecular diagnostics like
GeneXpert (Cepheid, CA) are replacing slow, growth-based Mtb detection as the reference standard globally,
most ATB is still diagnosed with sputum smear microscopy, despite its low sensitivity and specificity.
Our long-term goal is to transform TB diagnosis for all age groups with a blood or urine test that accurately
distinguishes patients with ATB from other pathologies, regardless of HIV co-infection. The objective of this
study is to demonstrate the analytical and clinical performance of a novel assay that combines the sensitivity of
our proof-of-principle bioelectrical TB (BET) assay with the ease of use of paper-based lateral flow
immunoassays (LFAs) to create a highly novel electrochemical LFA (eLFA) for point-of-need TB detection. Our
central hypothesis is that our proposed eLFA test will enable us to diagnose ATB with an accuracy that meets
or exceeds the WHO Target Product Profile (minimum accuracy: 90% sensitivity and 70% specificity for a
triage test for TB). We will achieve our objective through the following specific aims:
AIM 1: Determine the operating characteristics of the eLFA using contrived samples and bio-banked blood from
patients at risk for TB. We will obtain estimates of precision, cross-reactivity, and accuracy using GeneXpert
and culture status as references. AIM 2: Determine the operating characteristics of the eLFA using contrived
samples and bio-banked urine. We will obtain estimates of precision, cross-reactivity, and accuracy using
GeneXpert, and culture status as references, along with a combination of contrived and clinical samples.

Public health relevance
The objective of this project is to develop and validate a novel assay for diagnosing active tuberculosis (TB) disease from clinical blood and urine samples, addressing the limitations of current sputum-based tests. By combining highly sensitive bioelectrical TB detection with paper-based lateral flow immunoassays, the project aims to significantly improve the ease of use and diagnostic accuracy of TB testing for all patient groups, including those with HIV co-infection and extrapulmonary TB. In the short term, this assay could transform TB diagnosis and treatment, while in the long term, it has the potential to reduce TB transmission, mitigate drug resistance, and ultimately contribute to the global goal of ending TB.